Data Analysis and Modeling Core (DAM)

Data Analysis and Modeling Core – Abstract
The Data Analysis and Modeling (DAM) Core is designed to provide data processing and analysis services to the four Center Projects, the Career Enhancement Pilot Projects, the TCORS Consortium, and the FDA Center for Tobacco Products (CTP). The DAM Core will ensure that there are uniformly high data collection and analysis standards, as well as consistent measures of tobacco use across research projects. The DAM Core will also provide the infrastructure for disseminating the resulting tobacco use parameters (product-specific prevalence, initiation and cessation rates, and intensity of use by age, sex, year, and birth cohort), mortality rates by tobacco use status, modeling tools, and modeling results.